Training Program in Lung Biology and Disease

DESCRIPTION (provided by applicant): This is an application for continuation of the postdoctoral training program in lung biology and disease at the University of Texas Southwestern Medical Center. Training will be directed at the postdoctoral level, and the research training will be for two years in addition to any associated clinical training. The proposal is born out of a collaborative effort between divisions within the Pediatric and Internal Medicine departments involved in lung research at this institute, and is thus interdepartmental at its core. Our training faculty consists of experienced investigators representing 16 different clinical and basic science departments and centers, forming a solid, diverse training force, organized into four thematic tracks: 1) Pulmonary vascular disease; 2) Interstitial lung diseases; 3) Lung epithelial cell and differentiation disorders; and 4) Immunity/Inflammation/Sepsis. Besides mentor-based teaching, trainees will receive a comprehensive track- and project-specific didactic curriculum. Both clinical and basic science trainees will be guided by an individualized advisory committee that has both basic and clinical science mentors, to broaden the trainee's perspective and facilitate bench to bedside thinking. Emphasis will be placed on maintenance of project focus, creative experimental design, state of the art technology, and careful early career guidance.

Public health relevance
Project Narrative Lung diseases continue to account for most of the leading causes of death in the United States. Despite the need for further lung research targeted broadly at basic and clinical levels, there is a national shortage of clinically-directed scientists. The goal of the UT Southwestern Lung Biology and Disease Training program is to provide in-depth research training for postdoctoral fellows involved in adult and pediatric lung disease research, to invest in the future of lung-related research.